Genetic analysis in families with neurological disease

The identification of gene mutations causing disease lends new insight into the pathogenesis and etiology of the disorder under examination. In collaboration with NINDS and NHGRI we are performing a whole genome scan and high density autozygosity mapping of families with a variety of neurological diseases. [unreadable] We have identified a region of linkage within chromosome 4 in a large in-bred PD family, a region containing a segregating haplotype on chromosome 3 in a blepharospasm family and a segregating haplotype on chromosome 17 in the dystonia family. We have identified genetic lesions at the ITPR1 locus underlying spinocerebellar ataxia (SCA) 15; mutations at TTBK2 as the cause of SCA11; genomic duplication as the cause of SCA20 and novel mutations in a stress reponse gene as the cause of a young onset dystonia parkinonism.